Rapid and low-cost PFAS detection with advanced solid-state nanopore chips

Project Summary/Abstract
Perfluoroalkyl and polyfluoroalkyl compounds (PFASs) represent a class of emerging environmental
contaminants, resulting from their use in fire suppressants, and presence in landfill leachates and wastewater
treatment plant effluent and solids. The presence of PFAS in the environment is a serious concern since
they have exhibited hepatotoxicity, nephrotoxicity, thyroid damage, fetal and developmental toxicity, and
endocrine disruption. As we begin to understand more about their application and spread and how toxic
they can be, it is important and urgent to have a rapid and inexpensive way to detect PFAS. Multiple
methods, including LC-MS/MS, GC-MS and ion mobility exist for sensitive and selective detection of
PFAS in a variety of modalities. Unfortunately, these methods suffer from limited sample throughput, high
detection limits, high operational costs, complex operation, and require knowledge of the specific PFAS
chemical structure making them unsuitable for quantifying total PFASs. Several other detection techniques
are emerging but are not yet themselves able to reliably determine total PFASs in samples. We seek to
enable faster and lower-cost, but still reliable and robust, detection and quantification of total PFASs. This
project will chart as-yet unexplored territory in develop an advanced solid-state nanopore chip to meet these
urgent and comprehensive needs. Our nanopore instrument features a single-molecule precision and has
been used to detect DNA, RNA, proteins and small pharmaceuticals at low concentrations from different
forms of samples (liquid, solid, etc.). The approach will be enabled by a unique integration of advanced
nanofabrication, high-throughput data collection and reliable data analysis software to improve the overall
PFAS detection capabilities. Nanopore chips with tailored pore characteristics (diameter,
thickness, coating, etc.) will be fabricated, tested and validated and their storage, stability
and reusability will be systematically evaluated. We envision this platform as a first line
of defense against PFAS contamination for individuals and private and public
environmental protection organizations, and the engineering of an advanced solid-state
nanopore chip with single molecule resolution for even broader applications.

Public health relevance
Project Narrative Rapid, inexpensive, portable, and reliable detection of total per- and polyfluoroalkyl substances (PFASs) is important and urgent to protect human and ecological health. Here, we propose a novel method to detect and quantify total PFASs in the as-yet unexplored territory of a solid-state nanopore chip-based platform technology which can operate with single-molecule precision. By enabling a novel instrument that is faster, lower cost and more portable than traditional detection and analytical tools, this approach promises to provide public and private environmental protection organizations and individuals a reliable sensor for identifying PFAS contamination as the frontline of defense, thus helping to protect individuals’ health defend the health of our waterways.